Control of FSH in the female: inhibin and infertility

The broad goal of this project is to examine the neuroendocrine and gonadal regulation of FSH in the female. These studies will define the relative contributions of inhibins A & B to the control of FSH secretion and folliculogenesis during the normal menstrual cycle using correlation of daily FSH and inhibin A and B levels, estradiol and follicular size across the menstrual cycle. Populations will consist of both younger (age 18-34) and older (age 35-45)cycling women and in infertile women with high FSH levels.